Understanding and targeting fibroblast activation in influenza-triggered lung inflammation and post-viral disease

PROJECT SUMMARY
Influenza virus infection triggers lung inflammation and pathology and is a leading cause of acute respiratory
distress syndrome. Following viral clearance, lung inflammation and pathology can persist preventing recovery
from severe cases of infection. Such persistent lung inflammation and pathology, also referred to as Post-viral
Lung Disease (PVLD), is an underappreciated aspect of influenza virus infections, even though many patients
suffer extended hospital stays, and 25 – 50% of patients continue to experience respiratory symptoms for at
least 2 months after hospital discharge. Severe influenza virus infections also exacerbate other chronic
respiratory diseases, including COPD and idiopathic pulmonary fibrosis. Currently, there are no approved
pharmacologic interventions to improve recovery after viral clearance and to prevent or reverse PVLD and its
long-term effects. PVLD is characterized by the persistence of inflammatory immune cells in the lung tissue
and the failure of effective alveolar epithelial repair capable of restoring tissue function. The cellular and/or
molecular mechanisms driving the persistence of inflammatory immune cells and preventing effective alveolar
repair in the absence of ongoing viral replication are not known. We recently identified lung fibroblasts as
drivers of inflammation and influenza disease severity. We showed that a lineage of lung fibroblasts, which we
term inflammatory fibroblasts (iFibs), are especially important for driving pathogenesis, and not only promote
hyperinflammation, but also prevent restoration of normal alveolar function during acute infections. Our
preliminary data now demonstrate that these iFibs do not die during the acute phase of the infection, but
instead persist into post-viral stages of influenza disease. Together, these data allow us to hypothesize that a
subset of lung fibroblasts survives regulated cell death during acute IAV infection, differentiate into activated
iFibs, persist in damaged lung tissue well after viral clearance, and drive PVLD by continued production of
inflammatory mediators. We will test this hypothesis by addressing the following three key questions: (1) From
which cells, and when, do PVLD-driving inflammatory fibroblasts arise? (2) Do inflammatory fibroblasts persist
because they do not undergo regulated cell death, and (3) What is the therapeutic potential of inhibiting
persistent inflammatory fibroblast activity in PVLD? Successful completion of this project will identify a distinct
lineage of inflammatory lung fibroblasts as the cell type that initiates and drives PVLD and the mechanism of
their persistence following infection. This research will identify novel therapeutic entry points to prevent or
reduce PVLD before it develops to the point that it becomes irreversible.

Public health relevance
PROJECT NARRATIVE Severe respiratory viral infections, including influenza A viruses, are leading causes of lung inflammation and pathology. In severe cases of influenza, lung inflammation and pathology can persist after clearance of the virus and lead to long-term respiratory symptoms, referred to as post-viral lung disease (PVLD). This project seeks to define the role of lung fibroblasts in driving PVLD and determine if these cells are effective therapeutic targets to prevent or reverse this disease.